MRCE Live Cell Microscopy Core

This proposal describes the Live Cell Microscopy Core for the Midwest Regional Center of Excellence for Biodefense and Emerging Infectious Disease Research (MRCE). This Core is to provide MRCE, other regional centers and greater research community the ability to perform a variety of advanced fluorescence microscopy techniques with live BSL2 and BSL3 organisms. Before the facility was available, there was no regional option for performing advanced microscopy techniques on BSL3 organisms. The technical instrumentation and scientific expertise are also readily available to the public health community in the event of a bioterror, outbreak or pandemic event. Two fluorescence microscopes and a Laser-Capture Microdissection (LCM) microscope are available in the facility. The Nikon LiveScan Swept-Field Confocal microscope supports multi-dimensional data acquisition (x, y, z, time, wavelengths and multi-point), and the TILL Wide-Field microscope allows studies of ratio imaging (ions and pH) and FRET (Fluorescence Resonance Energy Transfer). Their super light sensitivity and video speed minimize photobleaching and phototoxicity, which is crucial for long-term imaging of fluorescent live samples. Cells are kept viable in a microscope cage-incubator that enables control of temperature, humidity and gas concentrations. Such livemotion imaging can be applied to explore dynamic localization, colocalization, trafficking, interaction and turnover between pathogen and cells, cellular organelles, proteins or ions. The LCM microscope enables detailed examination of extracted DMA, RNA and protein from targeted portions of histological sections. Perspective users will apply to the Core, and specific experimental protocols will be designed by the user in conjunction with the core PI. Biohazard safety issues will be resolved in conjunction with Dr. Susan Cook of Environmental Safety at Washington University, and appropriate clearances will be obtained in advance. Continued funding of this Core is required to increase the availability of cutting-edge microscopy for investigators in research community and in the event of an emergency to greatly advance our understanding biological mechanisms of pathogens.

Public health relevance
This project will provide renewed and continued funding to support a facility in which scientists can use sophisticated microscopes to investigate microbes that are too contagious to study in the normal environment. These studies will increase our understanding of how these organisms interact with our cells to cause diseases, and may therefore shed light on new ways to combat these serious disease-causing pathogens.